Minoirty Institutions Capacity Building Program

Through partnership with the Office of Minority Health, Office of Public Health and Science (OMH/OPHS), the NCMHD provided funds to support the DHHS Hispanic Association of Colleges &Universities (HACU) Professions Capacity Building Program.